Transcriptional Regulation Over Neurogenesis of Cortical Output Neuron Segmental Identity and Diversity

Subcerebral projection neurons (SCPN) reside in the neocortex, and extend axons to subcerebral targets in the
brainstem and spinal cord. Corticospinal neurons (CSN), a subclass of SCPN, project to the spinal cord and their
axons form the corticospinal tract (CST), a critical circuit for voluntary motor control. In addition, projections from
the neocortex to brainstem targets function in parallel with CSN to exert motor control. Degeneration of these
projection neurons in amyotrophic lateral sclerosis (ALS), along with degeneration of spinal motor neurons,
causes spasticity and paralysis. In humans, damage to the CST after spinal cord injury is a principal cause of
loss of voluntary motor control. Further, integrity of corticospinal connectivity is centrally linked to recovery from
stroke and cerebral palsy. There have been multiple investigations detailing the role of cortico-brainstem vs.
corticospinal projections in both motor control, as well as their distinct contributions to functional recovery in
these distinct causes of paralysis. However, it remains unclear when and how these distinct projections are
established during development. Understanding the molecular basis of this specification and differentiation
during development therefore holds significant promise in establishing approaches that are tailored to enhancing
plasticity of these related, yet distinct circuits. A necessary first step toward this ultimate goal is to identify the
molecular mechanisms directing SCPN axons to brainstem (cortico-brainstem neurons) versus spinal cord
(CSN). Ongoing work in our lab has identified that such projections are initially specified during the process of
axon extension during development. We have identified that cortico-brainstem and corticospinal neurons express
distinct genes and can be molecularly distinguished in mice by birth. Further our data suggest that the
transcriptional regulator Satb2 acts, in part, to specify cortico-brainstem neurons. This proposal investigates the
hypothesis that transcriptional regulation controls the development of cortico-brainstem vs. corticospinal
projections by late embryonic development in mice. Building on this foundation, we will first identify the time point
in development when these projections are specified using knock-in Cre reporter mice (Aim 1). This will be tested
using intracerebral injections of AAV-reporters at distinct developmental times in utero with adult analysis of
axonal projections. In Aim 2, we will investigate the transcriptional targets of Satb2 in SCPN at later
developmental times by profiling all SCPN in Satb2 WT and conditional KO mice, as well as by Satb2
overexpression, at single cell resolution. Finally, in Aim 3 using subpopulation-specific transgenic Cre lines, we
will investigate SCPN axon targeting in both Satb2 loss- and gain-of-function. In addition, we will investigate
whether misexpression of Satb2 target genes can alter SCPN targeting to the brainstem vs. spinal targets.
Together, our work will discern in-depth, the mechanisms of when and how transcriptional regulation controls
SCPN segmental “identity” thereby providing a mechanistic framework for subsequent identification of molecules
controlling segmentally appropriate SCPN connectivity with subcerebral targets.

Public health relevance
The proposed research is relevant to public health because understanding motor control circuitry is critical for recovery from paralysis resulting from multiple causes – stroke, spinal cord injury, traumatic brain injuries, motor neuron diseases, and cerebral palsy, which together represent a major cost burden, both in terms of health care costs as well as impact on quality of life of affected individuals and their loved ones. Successful and precise regeneration of this critical circuit, however remains an unattained goal in regenerative and translational neuroscience and hence better strategies are needed toward this end. Our proposed research will identify novel molecules that control the development of appropriate motor output circuitry and has direct applicability for (1) better strategies to promote and/or enhance regeneration and plasticity for functional motor recovery in vivo; and (2) directed differentiation of stem cells for disease modeling, and high-throughput drug screening in vitro.